Wisconsin Allergy Research Training (WISCART) Program

? DESCRIPTION (provided by applicant): The goal of the Wisconsin Allergy Research Training (WiscART) program is to provide research training for postdoctoral fellows in Allergy and Immunology to prepare trainees for careers as independent academic research scientists. Objectives to achieve this goal include helping trainees to establish a high quality and productive research project related to allergy/immunology, and developing abilities in leadership and education. There are generally 6- 8 Allergy/Immunology fellows in the UW program, and 4 fellows supported by the WiscART program. The trainees are post-doctoral students, or physicians who have completed residency training in either Pediatrics or Internal Medicine. For physicians, the Departments of Medicine and Pediatrics leverage the T32 funds by providing funds for salary support and stipends for additional training years not covered by WiscART. The WiscART trainers are a diverse group of clinical, translational and basic scientists, and there are an exceptional number of opportunities for trainee research projects. Training by traditional scientific and career mentorship is supplemented by exceptional educational programs offered by the University of Wisconsin CTSA (Institute for Clinical and Translational Research), including optional advanced degree and certificate programs in clinical research. Program accomplishments include high rates of recruitment and participation by underrepresented minorities and women, and a 50% rate of fellows pursuing academic careers upon graduation from WiscART.

Public health relevance
PUBLIC HEALTH RELEVANCE: Allergic diseases and asthma are among the most common diseases, and are increasing for reasons that are not well understood. The goal of this program is to provide training in clinical and translational research to physician scientists who wish to pursue academic careers devoted to research, education and leadership in these critical areas of unmet medical need.